Bidirectional control of Chd2 haploinsufficiency

ABSTRACT
Major advances have been made in mapping the genetic basis of epilepsy and other neurodevelopmental
disorders (NDDs). In many cases, a candidate gene mutation has been identified, but there is no robust
understanding of the neuronal causes for the particular disorder. Mutations in genes encoding chromatin
regulators are commonly identified in human NDDs, with intellectual disability, autism and/or epilepsy often co-
occurring in the same individual. Our recent work showed that mice with germline heterozygous mutations in
Chd2 exhibit pathological changes across genomic, anatomical, electrophysiological and behavioral domains.
Here, we propose studies to bidirectionally control Chd2 dosage in the developing or adult brain. Our approach
involves a combination of sophisticated cellular, molecular, pharmacologic and electrophysiological
approaches in conditional Chd2+/- mice and human-derived neurons. If successful, our results will provide
important new information about the effects of chromatin regulators in driving NDD-associated pathologies in
vivo and would provide critical proof-of-concept for the therapeutic potential of pharmacologically increasing
Chd2 expression that could be rapidly translated into a new targeted therapy for Chd2 haploinsufficiency.

Public health relevance
PROJECT NARRATIVE There is a critical unmet need for understanding the causes of rare neurodevelopmental disorders and to develop new precise treatments for these patients. The proposed research will evaluate how mutation in a chromatin regulator independently alters brain development and synaptic function in the brain. A secondary aim of this work is to test a novel therapeutic option for treating this disorder that could be rapidly translated to the clinic if our work is successful.